15-PGDH-Mediated Eicosanoid Degradation in Cardiac Fibrosis and Heart Failure

Project Summary/Abstract
Fibrosis is defined as excess deposition of extracellular matrix (ECM), resulting in tissue scarring and organ
dysfunction. In the heart, fibrotic remodeling in the context of chronic comorbidities such as hypertension and
metabolic disease is associated with increased passive myocardial stiffness and the development of diastolic
dysfunction (DD), a contributor to the pathogenesis of heart failure with preserved ejection fraction (HFpEF). The
adult heart contains resident cardiac fibroblasts (CFs), which, in response to stress, undergo a cell state transition
to become activated fibroblasts, sometimes referred to as myofibroblasts. Activated CFs are characterized by
transcriptional reprogramming that results in enhanced production and secretion of fibrotic ECM proteins.
Despite the well-recognized roles of CFs in fibrotic remodeling of the heart, there are no targeted therapies to
prevent or reverse the phenotypic conversion of these cells into an activated state.
Recently, we demonstrated that inhibition of the eicosanoid-degrading enzyme, 15-hydroxyprostaglandin
dehydrogenase (15-PGDH), using SW033291, potently suppresses murine and human CF activation, and blocks
cardiac fibrosis and ameliorates DD in vivo in mice. Eicosanoids are 20 carbon-containing lipid signaling
molecules that are produced by a variety of cells. Our data support a model in which stress signals trigger 15-
PGDH-mediated degradation of eicosanoids in CFs, resulting in reduced ERK1/2 signaling and subsequent
activation of the cells to promote fibrosis. SW033291 treatment prevents degradation of eicosanoids, resulting
in increased secretion of these fatty acids, which function in an autocrine and paracrine manner to promote
antifibrotic ERK signaling in CFs and ameliorate fibrosis of the heart. Three specific aims are designed to extend
this new field of cardiac research and test the overall hypothesis that inhibition of 15-PGDH promotes signaling
events that prevent and reverse the transcriptional reprogramming that typically culminates in CF activation and
pathological fibrosis of the heart.

Public health relevance
Narrative The proposed research is relevant to public health because developing novel treatment approaches for cardiac fibrosis and heart failure represents an urgent unmet societal need in the United States. Thus, the proposed research is highly relevant to the NHLBI’s mission to support medical research on heart failure, which affects ~6 million people in the Unites States and is a leading cause of mortality, hospitalization, and healthcare expenditures in our country. This proposed research is relevant to NIH’s mission to seek fundamental knowledge that will help to enhance health and reduce the burden of human illness and disability.